Basis of Gene Regulation by Purine and Cobalamine Riboswitches

Project Summary.
A widespread mechanism of gene regulation in bacteria is by a group of noncoding RNA elements called a
riboswitch. These are cis-acting elements found in the leader sequence of mRNAs and regulate gene
expression through their ability to directly bind a specific effector molecule to a highly-structured aptamer
domain. Effector binding to the aptamer domain is communicated to a downstream secondary structural switch
in the expression platform that instructs the expression machinery (generally RNA polymerase or the
ribosome). In a broad spectrum of bacteria, particularly Firmicutes and Fusobacteria, central metabolic
pathways including purine, amino acid, and cofactor biosynthesis and transport are regulated by riboswitches.
Furthermore, genes essential for survival or virulence are under riboswitch control in numerous medically
important pathogens including Listeria monocytogenes, Staphylococcus aureus, Pseudomonas aeruginosa,
Clostridium difficile, and Mycobacterium tuberculosis making them of great interest as novel targets for
antimicrobial therapeutics. Of equal importance, riboswitches are powerful model systems for understanding
various aspects of RNA biology including structure, folding and mechanisms of regulatory activity along with
developing tools and methodologies for designing small molecules that target other RNAs of medical interest.
Towards the long-term goal of developing a molecular understanding of how RNA interacts with small
molecules and the mechanisms it uses to regulate gene expression, we are using purine- and cobalamin-
binding riboswitches as model systems. This proposal details a set of interconnected specific aims that
addresses fundamental questions related to these research goals: (1) mapping sequence and structural
features of the expression platform beyond the structural switch crucial for efficient ligand-dependent
regulatory activity, (2) understanding how structural “modules” that mediate higher-order tertiary structure
contribute to rapid and efficient folding of the aptamer domain, and (3) investigating the plasticity of aptamer
domains through their ability to recognize different ligands. To address these questions, a combination of
structural (x-ray crystallography) biophysical (calorimetry and stopped-flow kinetics), biochemical (chemical
footprinting), genetic and molecular biological (in vivo and in vitro activity assays) and
bioinformatics/computational approaches will be combined to study the structure-regulatory activity linkage in
riboswitches. Significantly, this proposal adopts a “function-first” research strategy, as opposed to the
“structure-first” approach that dominates current research into riboswitches to make a stronger connection
between RNA structure and function. A deeper knowledge of how RNA specifically interacts with small
molecules that affects its structure and activity will contribute to ongoing efforts to develop a new generation of
therapeutics that target non-protein coding RNAs in bacteria and eukaryotes.

Public health relevance
Project Narrative (Relevance to Public Health). Riboswitches control expression of genes essential for survival or virulence in medically important pathogens such as S. aureus, P. aeruginosa and C. difficile. This research seeks to develop an atomic-level and mechanistic understanding of how riboswitch RNAs regulate gene expression through their ability to directly bind small molecule metabolites. These studies will advance our understanding into basic mechanisms of bacterial physiology and yield new insights into how to exploit RNA as a target of small-molecule therapeutics through structure-based drug design.